Mechanisms of astrocyte volume regulation and control of neural excitability

PROJECT SUMMARY
The volume-regulated anion channel (VRAC) is an outwardly rectifying anion channel that is activated in
response to cell swelling to initiate homeostatic regulation of cell volume. Upon opening, VRAC release Cl-
and other anions as well as negatively-charged osmolytes including glutamate into the extracellular space
(ECS) to initiate volume regulation in the cell. In brain, astrocytes have been found to regulate the ECS
and its contents through dynamic fluctuations in cell volume that correlate with sleep, consciousness,
alertness, and levels of synaptic activity. Therefore, VRAC may be especially important in astrocytes for
regulation of brain tissue excitability. Evidence suggests that astrocytic VRAC release glutamate in
conditions of cell swelling, contributing to ambient glutamate concentrations, stimulation of neuronal
glutamate receptors, and excitotoxic cell death in models of stroke. In epilepsy, it has been known for
many years that cell swelling is critical for the initiation and recurrence of seizures. Surprisingly, however,
the role of VRAC in network excitability, epileptiform activity, epileptogenesis, and seizure generation and
severity has never been directly tested. The long-term goal of our research is to identify molecular
mechanisms of brain tissue excitability and epilepsy. The objective here is to determine the contribution of
astrocytic VRAC to neuronal network excitability, seizure generation and epileptogenesis using astrocyte-
specific conditional VRAC knockout (VRAC cKO). Our central hypothesis is that astrocytic VRAC
significantly contribute to seizure generation, epileptiform activity, development of epilepsy, and pathology
associated with epilepsy including hippocampal sclerosis and neuronal cell loss through swelling-activated
release of glutamate. The rationale for the proposed research is that generation of new knowledge on
epilepsy mechanisms will lead to development of new therapeutic targets with fewer cognitive side effects.
First, we will determine the contribution of astrocytic VRAC in brain tissue swelling and seizure generation
in vivo. Second, we will measure the involvement and therapeutic potential of astrocytic VRAC in the
development of epilepsy using a combination of VRAC overexpression and rescue strategies in VRAC
cKO mice. Third, we will identify mechanisms of VRAC-mediated excitability changes and role in astrocyte
volume regulation at the cellular level. At the conclusion of these studies, it is our expectation that we will
have generated valuable new knowledge on astrocytic VRAC and its role in hyperexcitability, cell volume
regulation, seizure generation and epileptogenesis in situ and in vivo. These results are anticipated to
have positive impact by fundamentally advancing understanding of cell volume regulation, mechanisms of
glutamate release, and glial-neuronal interactions, while also providing novel targets for the treatment of
seizure disorders, excitotoxicity and epilepsy.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because the discovery of volume-regulated anion channel (VRAC) mechanisms controlling neuronal excitability will increase understanding of the pathogenesis of numerous neurological disorders and diseases including cerebral edema, stroke, ischemia, epilepsy, and Alzheimer’s disease. The project is relevant to NIH’s mission, as the research pursues fundamental knowledge of disease mechanisms and astrocyte-neuron interactions in the brain, which may provide a foundation for the development of novel and more effective strategies to treat neurological disorders.